Determining the Immunologic Effects of Trastuzumab Deruxtecan (T-DXd) in a Novel Chimeric HER2 Tumor Model

PROJECT SUMMARY
The aHER2 antibody-drug conjugate, trastuzumab deruxtecan (T-DXd}, has revolutionized breast cancer treatment,
prompting numerous clinical trials investigating immune checkpoint inhibitors (ICls} in combination with T-DXd.
However, few studies have explored T-DXd's immunologic effects, and comprehensive preclinical data supporting
ICI combinations is lacking. This challenge stems from trastuzumab's inability to bind to rodent HER2. Consequently,
many existing models rely on human-derived cell lines or xenografts transplanted into immune-deficient mice, thus
discounting T-DXd's immunologic effects. To address this, we have developed a robust, immunocompetent tumor
model to study trastuzumab-based therapies by minimally editing the mouse HER2 trastuzumab binding region,
which we termed HER2x. The HER2x tumor model binds trastuzumab, is nonimmunogenic, and is sensitive to TDXd
treatment. Preliminary experiments utilizing this model suggest that T-DXd induces immunologic memory
formation, potentiates responses in immune-competent compared to athymic nude mice, and increases tumor T cell
infiltration. Additionally, combining T-DXd with aPD-L 1 (an ICI) showed additive therapeutic benefits in pilot
experiments. Taken together, we hypothesize that T-DXd enhances adaptive antitumor immune responses through
modulation of the tumor microenvironment and can be further optimized through combination with ICls. To test this
hypothesis, Aim 1 will determine if T-DXd augments T cell-mediated antitumor immune responses in HER2+ breast
cancer models, and if this is necessary for treatment efficacy. HER2x tumors will be inoculated into
immunocompetent, syngeneic mice, which will then receive either T-DXd treatment or a vehicle control. At set
timepoints, tumors will be extracted for immune phenotyping via multiparametric flow cytometry, single-cell RNA
sequencing, and immunohistochemistry. In vivo T cell depletion studies will then establish the importance of CD4+
and CD8+ T cells for T-DXd efficacy in the HER2x model. Aim 2 will determine if combining T-DXd with aPD-1 or
aPD-L 1 provides improved and more durable responses in HER2+ breast cancer. HER2x tumors will be inoculated
as before, and mice will receive treatment with T-DXd, trastuzumab, or a vehicle control, in combination with aPD1,
aPD-L 1, or an isotype control. Survival and tumor volume will then be tracked until endpoint. All complete responder
mice will undergo a tumor rechallenge experiment to establish if combination therapy enhances tumoral
immunologic memory formation. Additionally, combination treated tumors will be extracted at set timepoints for
immune phenotyping to assess if ICI treatment alters T cell functional phenotypes in T-DXd treated tumors.
Completion of this proposal will deliver urgently needed insights into the immunologic mechanisms of T-DXd, with
the potential to provide clinically relevant and translational data supporting ICI combinations in patients. Furthermore,
the completion of this project will facilitate the development of my technical, critical thinking, and communication
skills that will be crucial to my success as independent translational oncology scientist.

Public health relevance
PROJECT NARRATIVE The antibody-drug conjugate trastuzumab deruxtecan (T-DXd) has revolutionized the treatment of HER2- expressing solid tumors, particularly HER2-positive breast cancers; however, it is being combined with immunotherapy in clinical settings without rigorous preclinical validation. A lack of immunocompetent preclinical models has impeded a comprehensive understanding of the immunologic effects of T-DXd and its potential benefits when combined with immune checkpoint inhibitors. This proposal will address this knowledge gap by leveraging an innovative chimeric HER2 tumor model to investigate the immunomodulatory effects ofT-DXd and its therapeutic potential in conjunction with immune checkpoint inhibitors, thereby providing pivotal preclinical data to guide and optimize the clinical integration of T-DXd with immunotherapies.